The Impact of the COVID-19 Pandemic on Veteran Caregivers: A Mixed Methods Study to inform the VA Caregiver Support System

Background: The COVID-19 pandemic has had cascading impacts for families and
communities. Concerns have been raised for potential negative physical and mental health
consequences due to the immediate risk of COVID-19 and the secondary social and economic
effects. Family caregivers may be especially vulnerable to short- and long-term impacts.
• Significance/Impact: Informal caregivers provide the majority of home and community-based
long-term care. A majority of functionally impaired Veterans rely on informal care for daily
support and condition management. Negative impacts from the pandemic have the potential to
reduce the capacity of informal caregivers to support Veterans choosing to remain at home.
• Innovation: There are no known studies of how the pandemic has impacted Veteran
caregivers. This study provides a unique opportunity to learn about an essential ally in the care
of Veterans, and the ways in which the VA system can enhance their support for Veterans
experiencing functional and clinical impairment. We uniquely combine an ecological systems
framework and the concept of “cascading effects” from disaster research to help us frame and
understand the different complex short- and long-term effects caregivers may experience.
• Specific Aims:
Aim 1. To describe both positive and negative caregiver experiences during the COVID-19
pandemic and to identify threats to long-term caregiver resiliency. We will conduct surveys with
Veteran caregivers from each of our 5 sites (San Antonio, Palo Alto, Miami, Salt Lake City,
Durham), to describe variability of impacts and to purposively sample caregivers for in-depth,
semi-structured interviews. We will triangulate findings from interviews with local VA caregiver
stakeholders.
Aim 2. To feedback preliminary data and debrief with VISN and national level VA stakeholders
to understand how these issues are perceived and responded to at a regional and national
level, and their priorities for caregiver services and research.
Aim 3. To engage Veteran caregivers in a participatory, deliberative process to identify top
priorities for future research and intervention.
• Methodology: We will conduct a 15-month, multi-sited, mixed methods study, utilizing a brief
Veteran caregiver survey, semi-structured interviews with caregivers and VA stakeholders, and
virtual focus groups with caregivers. We will focus on how caregivers have been impacted and
responded, VA organizational responses, and identifying priority areas for future research and
intervention.
Implementation/Next Steps: This pilot is a first step toward developing a long term
understanding of how Veteran caregivers and their capacity for caregiving have been and will
be impacted by the pandemic. It is an entry point for developing more tailored and sensitive
(e.g., to inequities) VA Veteran caregiver system supports. Our design includes feedback loops
to VA stakeholders and partners so that our findings may be actionable and inform ongoing
research and caregiver-centered, operations work.

Public health relevance
Informal caregivers play a critical role supporting Veterans with functional impairments who choose to remain at home. The COVID-19 pandemic has introduced stressors to an already strained and burdened caregiving system. However, there are no studies focused on how the pandemic has impacted Veteran caregivers. This project would use multiple methods to obtain a broad and deep understanding of caregivers’ experiences. We will survey and interview Veteran caregivers and VA stakeholders in San Antonio, Palo Alto, Miami, Salt Lake City, Durham. We will share preliminary findings with VA program office leaders and explore how programs, like the Caregiver Support Program, are working to address those needs. Finally, we will engage caregivers to set priorities for future Veteran caregiver research and intervention. By identifying caregiver impacts we will be able to inform caregiver-centered service and policy reforms.